Thalamo-hippocampal interplay in early life trauma-induced aggression

PROJECT SUMMARY/ABSTRACT
Understanding the top-down control of the neurobiological basis for aggression could help us identify ways to
reduce uncontrolled rage eliciting numerous social issues and economic burdens. Cognitive control that includes
abilities to pay attention is a fundamental ability essential for recognizing social cue and establishing social
relationships. Individuals with cognitive impairment like inattention, however, often externalize socially disruptive
behaviors, such as impulsive aggression. Notably, early life trauma (ELT), in the form of child abuse/neglect, is
a critical risk factor for cognitive decline and pathological aggression in later life, yet the neural circuit
mechanisms that transduce ELT into maladaptive neuronal changes resulting in impulsive aggression are not
well understood. The thalamic nucleus reuniens (RE), the largest midline thalamic nucleus, is thought to be a
key component connecting an extensive network between the ventral hippocampus (vHip) and medial prefrontal
cortex (mPFC). The RE highly expresses L-type calcium channels (LTCCs), potential therapeutic targets for
psychiatric diseases. Our preliminary data showed that mice received a systemic treatment of Bay K8644 (Bay
K; LTCCs agonist) display decline in cognitive performance with poor attention and impulsive responses during
the five-choice serial reaction time task (5-CSRTT), while they exhibit escalated aggression in the social context.
Likewise, a same set of behavioral phenotypes was observed in mice exposed to ELT (e.g., pup-dam/littermate
separation) who exhibit increased LTCC expression in the RE. We also found that optogenetic/chemogenetic
activation of the vGlut2 RE projecting to the vHip (vGlut2 RE vHip), but not vGlut2 RE mPFC, is sufficient to
induce the aggression in control mice, whereas optogenetic inhibition of vGlut2 RE vHip circuit normalizes
aggression of ELT mice. Our long-term goal is to test the hypothesis that vGlut2 RE vHip is the primary circuit
that mediates the maladaptive effects of LTCCs on early adversity-induced aggression. To achieve our objective,
we will first characterize the in vivo activity of vGlut2 REvHip neurons during aggressive behaviors of ELT
mice. We will examine whether ELT disinhibits in vivo vGlut2 RE vHip activity leading to increased neural
responses during aggression (Aim 1). Using CRISPR-Cas9 approach, we will then test whether LTCCs in the
RE circuitry are necessary for eliciting impulsive aggression associated with cognitive decline. Using molecular
profiling methods, we will further examine how ELT induces circuit-specific molecular adaptation in the vHip-
projecting RE neurons (Aim 2). Lastly, we will focus on circuit-specific role of the vHip in controlling ELT-induced
aggression. Using intersectional optogenetic manipulation, we will determine whether REvHip hypothalamus
circuit plays a key role in promoting impulsive aggression following ELT (Aim 3). Completion of these experiments
will transform our understanding of the social aggression associated with dysregulated cognitive control and
provide new insight into the circuit-specific roles of RE in driving the risk of maladaptive aggression that often
follows early adversities.

Public health relevance
PROJECT NARRATIVE The proposed research aims to address neural circuit mechanisms underlying impulsive aggression associated with cognitive decline following early life trauma (ELT). Our objective is to identify the key neural circuit component driving inattention and impulsive behaviors, such as aggression, by characterizing the glutamatergic neurons in the thalamic nucleus reuniens (RE) projecting to the ventral hippocampus. We also propose to examine how early adversities remodel L-type calcium channel activity to control RE circuit activity, thereby providing insight into targeted therapies for maladaptive aggression associated with cognitive decline.